The Development of a Bimodal Walking-Running Prosthetic Foot

PROJECT SUMMARY / ABSTRACT
Over the course of this two-year Phase II effort, Liberating Technologies, Inc. (LTI), along with its collaborators
at Fillauer Companies and Hanger Clinic, will refine, expand, and test a bimodal walking-running foot that would
then be poised to become a viable commercial product that can be reimbursed under the existing L-code
reimbursement structure. The goal of this project is to create a single foot that is optimized in each mode and
comparable to a walking foot when in a walking mode and a running foot when in running mode. This novel foot
would provide lower limb amputees who don’t currently have the access to running feet due to the lack of
insurance coverage, the opportunity to participate in running and other running-based activities (e.g. basketball,
etc.) to increase physical fitness. In doing so, the Caesar foot would also allow for the increased social
participation and the physical and mental health benefits that are associated with these activities.
In order to achieve this goal, we will progress and refine the bimodal foot technology with the achievement of the
following objectives: (1) iterate and optimize the design of the bimodal foot to achieve a fully functional prototype
ready for testing, (2) perform verification testing to confirm the prototype meets the design criteria, (3) validate
the prototype in a pilot take-home trial and assess its impact on the physical activity of lower limb amputees, and
(4) start preparing for an FDA submission for the Caesar foot.
The outcomes will be data that verify and validate the bimodal foot device in the laboratory and in the real world.
The product will be a highly advanced, commercially viable, verified, and validated bimodal prosthetic foot. This
innovative design allows us to address both of the identified primary barriers preventing LLAs from taking part in
these activities: 1) inadequately designed prostheses (by providing a foot with optimized design, alignment, and
biomechanics in both walking and running modes) and 2) the lack of accessibility for higher activity prostheses
(the cost of the foot would be covered by insurance).

Public health relevance
NARRATIVE The goal of this project is to develop a highly advanced, commercially viable, bimodal walking-running prosthetic foot that is optimized in two modes (a walking mode and a running mode) and can be reimbursed under the existing L-code reimbursement structure. This novel device would provide individuals with lower limb loss who don’t currently have access to running feet due to the lack of insurance coverage, the opportunity to participate in running, sports, and other social activities with a foot optimized for high-impact activities and the practicality of not having to switch sockets. Since it is optimized for walking and running, the unique design of the Caesar foot provides a substantial increase in functional benefit over the currently available hybrid feet, which although allow for walking and running do so by compromising the foot characteristics for each.